EVALUATION OF TESTODERM TESTOSTERONE TRANSDERMAL SYSTEM

To determine whether testoderm systems made by solvent cast and extrusion processes are bioequavalent with regard to serum testosterone concentrations attained and to describe the serum concentrations of DHT as a function of time during a 22 hour application of testoderm systems.